Novel 5-HT2A/mGluR5 Antagonist for Opioid Use Disorder

Opioid overdose deaths continue to be a major public health problem in the US requiring improvements in
treatments for opioid use disorder (OUD). Despite current medication for addiction treatment (MAT), treatment
dropout and substance use recurrence rates remain high. Thus, novel therapeutics to augment MAT to improve
treatment outcomes and reduce opioid overdose deaths are needed. Prior research suggests that 5-HT2A and
mGluR5 receptor antagonists could be useful in reducing impulsive responses to drug cues, improving negative
emotionality, and reducing the overall rewarding value of reinforcing stimuli, and through these mechanisms
improve treatment retention and reduce relapse in patients with OUD.
Vivozon Inc, has developed VVZ-2417- a new chemical entity, which has a high selectivity for 5-HT2A and
mGluR5 antagonism. In preclinical studies, VVZ-2471 reduces morphine self-administration, drug-induced
reinstatement of morphine self-administration after forced abstinence, and morphine withdrawal symptoms
precipitated by naloxone. In human studies, single and multiple ascending dose studies showed VVZ-2471 to
be safe in healthy controls with the most common adverse events being dizziness and gastrointestinal
symptoms, with no serious adverse events.
Taken together, preclinical, and early clinical safety data all support further research on VVZ-2471 as a
potential treatment for OUD. This project, which is a collaboration between Vivozon Inc and Virginia
Commonwealth University, will establish preliminary safety and early efficacy data to support VVZ-2471 phase
II clinical trials for a future NDA with the indication as an adjunctive treatment with buprenorphine for OUD.
UG3: Specific Aim 1. Establish the preclinical safety of VVZ-2471 when administered in combination with
opioids. Milestone 1. Completion of safety and drug-drug interaction (DDI) study in rodents for VVZ-2471 when
administered in combination with buprenorphine and separately with fentanyl. Specific Aim 2. Complete human
data collection and protocol development for IND submission for human phase Ib studies. Milestone 2.
Completion of a 30-day chronic dosing safety study in controls with no study drug related SAEs or unanticipated
problems affecting the UH3 IND. Milestone 3. Opening the IND without clinical hold for Phase 1b UH3 studies.
UH3: Specific Aim 3. Assess VVZ-2471 as an adjunctive treatment with buprenorphine in OUD participants in a
double-blind, randomized, placebo-controlled, double-blind phase 1b acute inpatient study assessing effects of
adjunctive VVZ-2471 (vs. placebo) on the PK and PD properties related to safety in OUD patients stabilized on
buprenorphine. Specific Aim 4. Complete a 14-day double-blind, randomized, placebo-controlled outpatient
extension of the trial of participants in Aim 3, assessing chronic safety as the primary outcome with secondary
outcomes of impulsivity, negative emotionality, and opioid cue-related attentional bias, and exploratory outcomes
of opioid craving, subjective reward, withdrawal symptoms, non-prescribed substance use.

Public health relevance
Opioid overdose deaths continue to be a major public health problem in the US requiring improvements in treatments for opioid use disorder (OUD). Despite current medication for addiction treatment (MAT), treatment dropout and substance use recurrence rates remain high. The overall goal of this project is to establish the preliminary safety and detect early signals of efficacy for the novel medication VVZ-2471 as a future adjunctive treatment with MAT for OUD.